Flexible, ultrahigh-throughput and easy-implementing distributed coincidence processor for improving PET imaging performance

This project aims to develop a new and innovative coincidence processor to overcome the limit and drawback of
centralized coincidence processor (CCP) that has been used by many commercial and research Positron
Emission Tomography (PET) scanners since the initial development of PET. Whereas CCP handles the entire
task of PET coincidence event selection with a single complex central processor, similarly to a computer central
processing unit (CPU), that it has the limited count-rate of processing coincidence data because of a single
processor and it is too complex to implement online on a field-programmable-gate-array (FPGA) for many
research groups without extensive expertise and resources, we propose to use a network of distributed
coincidence processors (DCP) that work independently and in parallel to process coincidence data for each
detector pair with its dedicated coincidence processor, similar to a graphics processing unit (GPU). By breaking
a single complex system-level coincidence process into many simple detector-pair-level processes, DCP can
significantly reduce the processing delay at each CP level and therefore increase the overall data throughput,
even with a large number of detector pairs. The algorithm for coincidence event selection with a single detector
pair is simple and can be easily implemented, tested with one detector pair and be straightforwardly replicated
(or populated) to the rest. The goal of this proposed project is to design, implement, evaluate, enhance, and
disseminate the proposed DCP technology. We will pursue three specific aims to achieve this project goal: (1)
To design DCP technology, including the hardware infrastructure of DCP components and functions and
firmware program to realize the design DCP components and functions on FPGA. (2) To implement DCP on a
single FPGA board with 400 coincidence processors as a practical solution to a PET with small to medium
number detector pairs, and on two FPGA boards with 50 coincidence processors on each board as an example
of an expandable solution to a PET with a large number detector pairs; to evaluate DCP with pulsed signals and
PET detectors, and enhance the DCP capability and performance with an iterative design and development
process. 3) To document and disseminate DCP technology through publications and a website with
downloadable technical documentations and firmware/software code. If successfully developed, DCP will
provide a novel and different technology platform for coincidence processing to solve the problems with CCP.
As a game changer, DCP can yield a very high count-rate PET online coincidence data acquisition far beyond
the limit of what CCP can provide and can be implemented on FPGA with much less technical challenging than
implementing CCP. By addressing the problems with CCP and providing the solutions to the research community,
this project would have a transformative impact on improving the capability and performance of PET imaging
and accelerating the development of new PET systems and technologies.

Public health relevance
To significantly improve the current PET performance of online coincidence data acquisition that is limited by the existing centralized coincidence processor (CCP) and drastically reduce the technical challenging to implement CCP, this project aims to design and develop a new technical platform of coincidence processing technology with distributed coincidence processors (DCP) that can be efficiently implemented on FPGA. The new technology is innovative and original, yet still practical, as it is based on the existing FPGA and PET instrumentation technologies. The success of this project will push PET performance boundaries beyond the limit of CCP and substantially minimize the effort of CP implementation, which will have a significant impact on accelerating the new PET system development and improving PET imaging research and applications.